Exploring 2-Biaryl-ELQs for Targeting the Qo and Qi sites of P. falciparum cyt. bc1

Background and Innovation: Malaria is a potentially fatal tropical disease spread from person-
to-person by Anopheles mosquitoes. Over 200 million clinical cases of malaria occur around the
world each year along with roughly 600,000 deaths. The global situation is worsening due
to widespread resistance to virtually all drugs that have been put into clinical use. This
application seeks support for research to optimize the 2-arylquinolone scaffold for
targeting of the Plasmodium falciparum cytochrome bc1 complex, an ideal target given its
critical importance to parasite survival in the liver, blood and vector stages of its life cycle.
Significance and Impact to Veterans Healthcare: Malaria and antimalarial drugs are two of
the most common biological and chemical exposures of US warfighters. Our long-term goal
is to develop a 2-arylquinolone to provide protection against multidrug resistant malaria
parasites. Given our experience we believe that we can design 2-arylquinolones to selectively
inhibit the malarial cytochrome bc1 complex, a privileged target that is critical to the survival of
the parasite in all life cycle stages of development. We will design of 2-arylquinolones to provide
a preclinical candidate for use is preventing and treating malaria in humans. Optimized
drugs could be delivered by once-weekly or optimally once-monthly oral dosing to improve
compliance or by long-acting injectable formulation for seasonal protection against disease.
Protection against malaria avoids the potential for toxic exposures to fever, seizures, and
high drug levels that might otherwise have negative and long-term side effects for soldiers
and veterans.
Path to translation/implementation: We have previously discovered and developed lead
candidate drug molecules that have advanced to preclinical status and ultimately on to clinical
development by the Medicines for Malaria Venture: ELQ-300 and ELQ-331. More recently,
ELQ-596 and its prodrug ELQ-598 have been taken up by the MMV and advanced to pipeline
status. Our vision is to identify a gap in knowledge or treatment and to work toward filling the
need. Here we seek to develop a 2-arylquinolone that targets a critical enzyme in the
parasite’s electron transport pathway and that works synergistically and operationally together
with other anti-respiratory drugs including the ELQs and clinical drug atovaquone. We envision a
cocktail of anti-respiratory drugs, including an ELQ and an optimized 2-arylquinolone, that can be
used in mass administration campaigns to support the worldwide eradiation of malaria. Our
current path to translation of our findings to a clinical candidate involve partnering with the
Medicines for Malaria Venture and/or the Division of Experimental Therapeutics at Walter Reed
Army Institute of Research for advancement to clinical studies.

Public health relevance
Malaria and antimalarial drugs are among the most common biological and environmental exposures of US combat veterans. Malaria is a potentially lethal tropical infection that is spread from person-to-person by Anopheles mosquitoes. Clinical management of malaria infection is complicated by widespread drug resistance to virtually all drugs that have been released for clinical use. Development of new, safe and more potent antimalarial drugs that can be used to prevent and treat active infections as well as for transmission blocking is the subject of this application. Successful development of this novel class of antimalarial drugs for clinical use will enhance protection against lethal malaria and avoids the potential for toxic exposures to high fever, seizures, and high drug levels that might otherwise have negative and long-term side effects for US warfighters and veterans.